DETERMINING AND COMPARING THE PHARMACOKINETICS OF [D10]PHE IN SMOKERS AFTER ORAL

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of this project is to contribute to the development of a predictive model for lung cancer susceptibility in smokers.